IRACDA at UCSC and CSUMB

Project Summary
Our IRACDA program is a partnership between the University of California at Santa Cruz (UCSC) and
California State University at Monterey Bay (CSUMB), both Hispanic Serving Institutions located in central
California. This program takes a 2-pronged approach to address underrepresentation of minorities in STEM
research: 1) provide postdoctoral scholars with a rigorous research environment at UCSC and with expert
training in inclusive teaching and mentoring skills at CSUMB; 2) shrink the achievement gap of URM students
in STEM by providing CSUMB undergraduate students with additional research mentorship by postdoctoral
fellows.
Throughout the 4-year training period, structured mentoring by research (UCSC) and teaching
(CSUMB) mentors will ensure that all postdocs receive consistent feedback with respect to the development of
research skills, pedagogy training, and career planning. Mentoring has been shown to be a key factor for
success in obtaining academic faculty positions, especially for trainees from groups underrepresented in
biomedical research. In addition to mentoring and hands-on research and teaching training, the program
incorporates classes and workshops on writing (grants and teaching statements), evidence-based pedagogy,
practice of science (Rigor and Reproducibility, Responsible Conduct of Research), leadership, and interview
skills.
At UCSC, the IRACDA scholars will join research laboratories affiliated with the Institute for the Biology
of Stem Cells, which includes a large variety of research areas within the focus of the NIGMS mission. At
CSUMB, the Department of Biology and Chemistry will mentor the IRACDA students in lecture and laboratory
classes and in research-focused classes designed predominantly for URM students.
CSUMB and UCSC have longstanding partnerships, including research collaborations, summer
research programs for CSUMB students at UCSC, postdoctoral teaching mentees at CSUMB, and regular
seminar presentations by UCSC faculty at CSUMB. We anticipate that this IRACDA program will further
stimulate exchange between CSUMB and UCSC to strengthen the overall exposure and opportunities for our
students, postdoctoral scholars, and faculty.

Public health relevance
Narrative Our proposed IRACDA program is a collaboration between the University of California at Santa Cruz (UCSC) and California State University at Monterey Bay (CSUMB), both Hispanic Serving Institutions in central California. The program aims to contribute to an increase in the number of underrepresented minorities in faculty positions in the biomedical field. UCSC postdoctoral scholars will receive rigorous research and teaching training by structured mentoring from UCSC and CSUMB mentors to ensure targeted career skill development; undergraduate STEM students at CSUMB will benefit from augmented mentoring by the IRACDA postdocs in classes and research settings, and by exposure to world class biomedical research.